Patient, Partner, and Provider Determinants of Postpartum Contraception and Inter-Pregnancy Intervals

ABSTRACT
Nearly 1 in 5 postpartum patients will have a repeat pregnancy after a short interpregnancy interval (sIPI), defined
as less than 18 months between a prior birth and subsequent conception. Several adverse outcomes are linked
to sIPI, including preterm delivery, low birth weight, and infant mortality. Risks are greatest for shorter IPIs and
unintended pregnancies. Guidelines therefore recommend clinicians advise postpartum patients to avoid a sIPI
of <6 months and consider delaying pregnancy for 18 months; contraceptive options should also be discussed.
Yet up to 40% of patients never receive any postpartum care, missing opportunities for counseling. Health
system factors, like fragmentation in care and difficulty scheduling and navigating visits, are frequently cited
barriers. Among patients who do attend postpartum care, only half receive counseling on healthy birth spacing.
While contraceptive counseling is usually provided, it is rarely comprehensive or patient-centered. As a result,
most patients are unaware of the consequences of sIPI and the time recommended between pregnancies. Nearly
half do not use any postpartum contraception or use a less effective method, increasing risk of repeat pregnancy.
On the patient-level, the role of psychosocial (e.g., depression, stress) and behavioral (e.g., alcohol use,
sleep) factors on postpartum contraceptive use and sIPI are poorly understood, despite the considerable physical
and mental demands of the postpartum period. Similarly, the impact of low health literacy, or difficulty `finding,
understanding, and using information to inform health actions' has been linked to worse contraceptive knowledge
and poor understanding of fecundity, but has not been studied in relation to postpartum contraceptive use or
sIPI. Finally, despite reproduction being a dyadic behavior, partner-level factors, including partner health literacy
and partner-reported psychosocial and behavioral factors, and their impact on postpartum contraceptive use and
sIPI remain understudied. Research has also not considered how these factors vary and interact within a dyad.
Unraveling these relationships can provide crucial information on how - and who - to target in future interventions.
To address these evidence gaps, we will conduct a longitudinal cohort study among 960 English- and
Spanish-speaking postpartum patients recruited from academic and community health centers in Chicago, IL
and any eligible, cohabitating partners (N=400). Data will be collected at 6 timepoints over 21 months to capture
modifiable, multilevel factors affecting postpartum contraceptive use and unintended sIPI. Our aims are to:
1) Examine the effect of patient health literacy and psychosocial and behavioral factors on birth spacing
knowledge, postpartum contraceptive method choice, use, and unintended sIPI; 2) Investigate the impact of the
health system on patient postpartum care utilization, birth spacing knowledge, postpartum contraceptive method
choice, and unintended sIPI; and 3) Among dyads, explore the influence of patient and partner health literacy
and psychosocial and behavioral factors on postpartum contraceptive method choice, use, and unintended sIPI.

Public health relevance
PROJECT NARRATIVE Our Patient, Partner, and Provider Determinants of Postpartum Contraception and Inter-Pregnancy Interval (P5) study will examine determinants of postpartum contraceptive use and unintended, repeat pregnancy within 18 months of a prior live birth. We will investigate modifiable factors at the health system, patient, partner, and couple level to inform future intervention efforts. This is important, as having pregnancies too close together, called a short interpregnancy interval, has been linked to worse maternal and infant outcomes, particularly when pregnancies are unintended.